NCI Community Oncology Research Program (NCORP) Community Sites (UG1 Clinical Trial Required)

SCOR Project Summary/Abstract
The Southeast Clinical Oncology Research Consortium (SCOR) is a unique organization
comprised of 21 community members from rural and metropolitan areas under the leadership of
three experienced Principal Investigators (PIs), a Leadership Council, and the SCOR
Operations Center (SOC). The members comprise small community hospitals, hospital systems,
and private practices in a six-state geographical area (Florida, Georgia, North Carolina, South
Carolina, Tennessee, and Virginia). The primary goal of this application is to bring NCI clinical
trials and Cancer Care Delivery Research (CCDR) to the catchment area. A second goal is to
facilitate the use of effective, evidence-based practices to improve the quality of care, health
outcomes, and reduce cancer health care disparities. There are currently 230 investigators and
160 clinical research staff across 93 treatment performance sites engaged in National Cancer
Institute (NCI) research. Each community has a Community Responsible Investigator to oversee
research and to ensure human subjects protection. SCOR has a Young Investigator Mentoring
Program designed to increase participation of the next generation of NCI investigators in cancer
clinical research. Each community also has a research coordinator who is responsible for
clinical operations. The SCOR catchment area includes over 16 million people with significant
ethnic, rural, and medically underserved populations. The SOC in Winston-Salem, NC provides
extensive expertise, regulatory assistance, training, monitoring, mentoring, education, and
coordination to facilitate member community’s ability to provide clinical trials to their patient
population. SOC staff conducts at least yearly site visits to each community member to review
their research program and recruitment strategies, to ensure compliance and quality data
submission, and to assist with audit preparation. This infrastructure allows understaffed member
communities to conduct NCI clinical research. The efficient, centralized SOC and experienced
PI leadership will facilitate accomplishment of the goals of this application.

Public health relevance
SCOR Project Narrative Advances in oncology are made through the execution of well-designed innovative clinical trials, including participation in Cancer Care Delivery Research, and these advances will lead to improved quality of life and health outcomes, as well as reducing cancer health disparities. This 21-community organization has the expertise, strength, capacity, and capability to contribute to these outcomes. Through covering a six-state area, this organization provides clinical trial access to small, rural, medically underserved, and Appalachia communities of the Southeast.